Alcohol Research Consortium in HIV: Ending the HIV Epidemic through interventions and Epidemiology at the intersection of the alcohol and HIV care Continua

Established in 2011, the Alcohol Research Consortium in HIV (ARCH) conducts high impact epidemiological
and intervention studies that address relationships between at-risk alcohol use and AUD, the HIV Care
Continuum (HIV-CC) and health outcomes. ARCH is embedded in and has capitalized on the research and
clinical infrastructure of the CFAR Network of Integrated Clinical Systems (CNICS), an eight site clinical cohort
of university-based HIV clinics across the US, with many of these clinics located in high priority regions for
Ending the HIV Epidemic (EHE). The overarching theme of the proposed P01 is to expand scientific knowledge
and treatment interventions at the intersection of the Alcohol-Care Continuum (Alc-CC), HIV-CC and HIV
related comorbidities across the full spectrum of alcohol use -- with particular attention to individual context and
social determinants of health -- using implementation and epidemiological research. Our scientific goals are: 1)
To implement evidence-based alcohol interventions (EBI) across the alcohol use spectrum among PWH using
rigorous hybrid-implementation effectiveness designs; 2) To understand how multi-level contextual factors
impact the alcohol use spectrum, the Alc-CC and HIV-CC, comorbidities, and intervention responses among
PWH; 3) To determine optimal alcohol reduction targets (e.g. abstinence v low-risk drinking, reduction in WHO
risk score) among PWH in the context of the Alc-CC, HIV-CC and HIV-related comorbidities. This ARCH P01
has three research projects. We are proposing a Hybrid Type III effectiveness-implementation trial integrating
alcohol EBIs into HIV clinical care. This study is a direct extension of our earlier research findings
demonstrating a robust effect of a computerized brief intervention embedded in a stepped care treatment
approach for PWH with at-risk drinking. Our second project is a Hybrid Type1 effectiveness-implementation
pilot trial developing and testing a novel relapse prevention intervention (RPI) for PWH. The importance of our
focus on RPI is highlighted by our recent finding that any alcohol use among PWH with AUD is associated with
increased viremia and the well-established high relapse prevalence of 50 – 75% of persons in remission. Our
epidemiological project will provide outcomes data for the intervention trials as well as examine the full
spectrum of alcohol use, the Alc-CC and their relationship to HIV-CC, comorbidities and co-infections in the
context of social determinants of health. An administrative core provides the structure and processes to
support collaboration and synergy across ARCH projects and investigators. A biostatistics and methods core
supports analyses for the three projects and development of novel analytic methods. A transdisciplinary group
of investigators brings depth and breadth of expertise to this program. Building on a decade of collaborative
research progress and administrative structure in ARCH and capitalizing on the extensive resources of CNICS,
this P01 proposal addresses issues of high relevance to the US goal of ending the HIV epidemic and the Office
of AIDS Research priorities, including HIV Treatment as Prevention, HIV related comorbidities and disparities.

Public health relevance
At-risk alcohol use, alcohol use disorder and return to drinking can have negative impacts on people with HIV (PWH). We propose to integrate alcohol reduction and relapse prevention interventions into HIV clinical care settings and to study the long-term effects of the spectrum of alcohol use on the alcohol and HIV care continua, comorbidities and disparities among a large, multi-site cohort of PWH.